Promoting cognitive screening and assessment post-aneurysmal subarachnoid hemorrhage for better equity in outcomes

PROJECT SUMMARY/ABSTRACT
Aneurysmal subarachnoid hemorrhage (aSAH) is a form of stroke that strikes relatively young, working-age
individuals (typically 30-60 years old; mean age ~50 years old). Cognitive symptoms post-aSAH impair quality
of life (QoL), with disparities seen in African American (AA) patients, rural patients, and those individuals of
lower educational and socioeconomic status. Notably in our preliminary data, cognitive symptoms have gone
undiagnosed in ~67% of survivors, as these symptoms are not captured by typical outpatient clinical
neurological exams or commonly used general mental status screening modalities. Furthermore, the gold
standard of measuring post-aSAH cognitive impairments with neuropsychological testing is frequently
unavailable or neglected, and there are no existing guidelines regarding when to trigger such referral. But if
these changes are accurately detected and patients are referred, cognitive interventions have shown success
in improving outcomes in this population. In short, inadequate detection and phenotyping of cognitive
symptoms by clinical neurological exam and/or general mental status screening, in conjunction with non-
existent guidelines for in-depth assessment, places patients at risk for cognitively driven poor outcomes and
reduced QoL, a risk that is greater for AA and rural patients, but an outcome that is amenable to intervention.
The novel central hypothesis of this proposal is that the Quality of Life in Neurological Disorders (Neuro-
QoL), a patient-reported outcome (PRO) battery of questionnaires, can fill this gap in screening for clinical
decision-making. Our strong preliminary data demonstrate that the cognitive short form within the Neuro-QoL
(NQ-CSF) provides a simple yet critically needed screening tool for use in aSAH survivors; however, this
instrument has not yet been tested a) as a benchmark to trigger individual patient referral for in-depth
neuropsychological assessment; b) for interpretation in relation to other relevant demographic and clinical
information; or c) for interpretation in relation to other Neuro-QoL measures. Furthermore, responses on this
instrument have not been considered in regard to social determinants of health (SDOH) data that may impact
reporting and interpretation or create enhanced screening needs for diverse groups of patients. We respond
here to PA-19-053 and NOT-OD-20-079, and the spirit of PAR-22-231, to propose one highly focused aim:
Determine the utility of the Neuro-QoL cognition short form (NQ-CSF) as a benchmark to trigger
individual patient referral for in-depth clinical neuropsychological assessment. This project is
innovative for applying the Neuro-QoL for clinically meaningful cognitive symptom screening and
individualized patient referral post-aSAH. The work will have a significant impact by informing new practice
guidelines to improve equity and to provide earlier and more accurate assessment of cognitive
symptomatology. Lack of such knowledge reduces QoL for these individuals.

Public health relevance
PROJECT NARRATIVE The proposed research addresses a gap in clinical decision-making for the assessment of cognitive symptoms after aneurysmal subarachnoid hemorrhage (aSAH; a form of stroke), a burden that is disproportionately felt by African American (AA) patients and those that reside in rural areas. Specifically, we propose to investigate the application of the Quality of Life in Neurological Disorders (Neuro-QoL) patient-reported outcome measures and, in particular, one of its components—the Neuro-QoL cognition short form—as a screening tool to support clinical decision-making and trigger individual, in-depth cognitive assessment post-aSAH. This work will improve health equity by informing new practice guidelines to provide earlier and more accurate assessment of cognitive symptomatology post-aSAH to reduce disparities and improve quality of life (QoL) for survivors.